Core D: Research Experience and Training Coordination Core

PROJECT SUMMARY/ABSTRACT – RESEARCH EXPERIENCE AND TRAINING COORDINATION CORE
N-Nitrosamines are a family of chemicals that include some of the most potent mutagens known. N-Nitrosamines
are a major concern for people who live near the Olin Chemical Superfund Site, and they are also a concern of
the Passamaquoddy Tribe, because the water treatment methods used for their drinking water are known to lead
to formation of N-nitrosamines. The mission of the Research Experience and Training Coordination Core
(RETCC) is to recruit, train, and engage the best and the brightest students for careers in Biomedical Research
(BMR) and Environmental Science and Engineering (ESE) with a focus on public health. With support from the
RETCC, trainees will participate in all of the proposed research, engagement, and translation activities, and they
will contribute data to and benefit from the Data Management and Analysis Core (DMAC). As such, trainees fuel
the entire MIT SRP program. By fostering and enabling interactions among trainees and between trainees and
leaders, the RETCC supports an innovative Systems Approach of inter-dependencies among subsystems
(Projects and Cores). Via a Systems Approach, all trainees impact and are impacted by all of the Projects and
Cores via a network of connections that are fostered by the Administrative Core and the DMAC. Data generated
by trainees will be managed by the Data Management and Analysis Core and will be integrated with data from
other parts of the program to contribute to risk evaluation. Innovative aspects of the RETCC include cross-
disciplinary research opportunities, training in how research can be leveraged to impact policy, and a new “MIT
SRP Exploration Program” that enables trainees to spend time in other MIT laboratories. In addition, there will
be several approaches to support pipeline development so as to increase the number of top students with diverse
backgrounds and expertise pursuing careers in environmental health sciences and engineering. This work will
include creating an MIT undergraduate research opportunity that focuses on SRP research, a new “Public Health
Democratization” Pipeline Project to connect URM SRP Trainees with younger URM students. Specific Aim 1
is to provide opportunities to trainees for research, translation, community engagement, and data
analysis that will help protect human health from hazardous chemicals. Specific Aim 2 is to strengthen
and create programs to promote professional development. Specific Aim 3 is to recruit and promote
diverse students and postdocs. Specific Aim 4 is to provide formal training to ensure that MIT SRP
trainees have successful and responsible careers in biomedical research and environmental science
and engineering. The Administrative Core will foster opportunities for trainees to participate in research
translation, which includes interactions with stakeholders. Furthermore, the Community Engagement Core (CEC)
will open doors for trainees to work with community members, including helping to deploy sensors and a filtration
device that will destroy N-nitrosamines. Taken together, the RETCC provides the foundation upon which trainees
thrive and enables the collective impact of the entire program.

Public health relevance
PROJECT NARRATIVE – RESEARCH EXPERIENCE AND TRAINING COORDINATION CORE The Research Experience and Training Coordination Core (RETCC) recruits the best and the brightest trainees, provides cross disciplinary research training, and propels all of the activities of the MIT Superfund Research Program that, together, enable protection of people from the effects of hazardous chemicals. The RETCC coordinates with the Administrative Core and the Community Engagement Core to ensure that trainees have exciting research translation opportunities (and regular contact with community members and organizations at the local, state, national, and tribal levels), as well as opportunities to listen to, learn from, and collaborate with community members and tribes. By fostering teamwork and nurturing trainees with a supportive environment, strong mentorship, and formal and informal enrichment activities, the MIT SRP trainees will continue to promote the public health impact of the MIT SRP.